Dual-Task Training Exercise to Reduce Falls in Older Adults with Mild Cognitive Impairment

PROJECT SUMMARY/ABSTRACT
Non-pharmacological interventions, such as physical exercise or movement therapies, to prevent falls in older
adults with mild cognitive impairment (MCI) have not been effective. Our long-term goal is to establish a safe
and efficacious mind-body exercise intervention that can be made widely available in community settings and
for clinical practice to prevent falls in a rapidly growing, at-risk population of community-dwelling older adults
with MCI. The objective of this proposal is to evaluate a novel intervention—dual-task Tai Ji Quan: Moving for
Better Balance (Dual-TJQMBB)—that is specifically tailored for older adults with MCI to prevent falls. The
rationale underlying this proposal is that by integrating cognitive exercises with physical (tai ji quan)
movements we address the impaired balance and concomitant attention (dual-tasking) deficits associated with
the increased risk of falling in this population. The central hypothesis is that our therapeutically tailored and
dual-task augmented tai ji quan training approach will be more efficacious than traditional tai ji quan training in
preventing falls. The central hypothesis, with its premise established from our prior work and promising pilot
data, will be tested by pursuing our Primary Aim in which we will determine the efficacy of a 6-month Dual-
TJQMBB intervention in reducing the incidence of falls among older adults with MCI. We will address our
Primary Aim using an innovative e-health (online) intervention delivery approach with a 3-arm, single-blind,
randomized controlled trial involving a test of the comparative efficacy of the two tai ji quan fall prevention
interventions (Dual-TJQMBB, standard TJQMBB) relative to a stretching control. We hypothesize that, by
month 6, participants assigned to the Dual-TJQMBB intervention will show a significant reduction in the
incidence of falls (primary outcome) and improvement in dual-task walking and physical and cognitive
performances (secondary outcomes) compared to those assigned to the stretching control. The project has two
secondary aims: (1) to determine how well the benefits of our Dual-TJQMBB intervention persist over a 6-
month post-intervention follow-up, and (2) to examine whether the impact of Dual-TJQMBB training on
reducing the incidence of falls is mediated by change in dual-task walking performance. Our proposed
research is significant because it will fill a vital gap in clinical practice by providing efficacy evidence about a
tailored fall prevention intervention that combines tai ji quan with cognitive task training, for the first time, for
older adults with MCI who are at risk of falling and continuing cognitive decline. If the evidence supports the
Dual-TJQMBB hypothesis, the proposed study can (a) make a rapid impact on clinical practice guidelines in
the field of fall prevention and (b) have a widespread positive impact very quickly because it can be coupled
with the standard TJQMBB program, which has been broadly disseminated across the country.

Public health relevance
PROJECT NARRATIVE The evidence that physical exercise reduces falls in older adults with cognitive impairment is currently both limited and inconclusive, making it difficult for recommending best practices. The proposed study is intended to fill this gap. The primary objective of this project is to determine the efficacy of the therapeutically tailored, cognitively enhanced, dual-task Tai Ji Quan: Moving for Better Balance intervention in reducing the incidence of falls among older adults with mild cognitive impairment, a population that is at an increased risk of falling and increased risk of developing Alzheimer’s disease and Alzheimer’s disease-related dementias. Because the problem of falls is directly relevant to the growing aging population in the United States, our project has the potential to have broad societal impact by ameliorating risk of falls in older Americans with cognitive impairment, improving their physical and cognitive health, and lessening the health care burden due to falls and falls injuries and cognitive decline.